UofL Environmental Health Sciences Training Program

? DESCRIPTION (provided by applicant) The investigators have made strategic changes in their environmental health sciences training program in response to the announced restructuring and redirection of NIEHS training programs. Participating Centers, Institutes, and Schools and the members of the training faculty provide critical resources for cutting edge basic science, clinical research, computational sciences and public health. Environmental health science partnerships have resulted in a very successful NIEHS training program in environmental health sciences. The renewal application incorporates and integrates several Schools, Centers, and Institutes. The investigators propose a substantially improved pre-doctoral and postdoctoral training program that serves as an umbrella for interdisciplinary and integrated approaches to environmental health sciences. The training program will support six pre-doctoral and three postdoctoral trainees. Initial student recruitment and funding for pre-doctoral trainees is provided by the University of Louisville Integrated Programs in the Biomedical Sciences recruitment gateway. As in the first cycle, pre-doctoral trainees will not be recruited directly into the environmental health sciences training program. All faculty mentors are asked to nominate trainees who have completed an approved dissertation proposal with a defined focus in environmental health sciences research. Faculty mentors will be asked to nominate either existing postdoctoral fellows (for example those already matriculated into the Clinical Chemistry and Toxicology Translational Sciences Program) or from trainees to be recruited. Teams of mentors (basic and clinical scientists or basic and population-based scientists) will be particularly encouraged to emphasize the importance of multidisciplinary training and translation of basic science findings to the patient and/or community. The training program facilitates multidisciplinary approaches for effective intervention and interfaces exceptionally well with the NIH Roadmap as well as with the strategic plans of NIEHS and the University of Louisville.

Public health relevance
PUBLIC HEALTH RELEVANCE: The environmental health problems faced by the nation are multi-factorial in nature, and therefore require multi-disciplinary approaches for effective intervention. The training program emphasizes the importance of multidisciplinary training and translation of basic science findings to benefit the patient and/or community. This multi-disciplinary translational program interfaces with the NIH Roadmap and the NIEHS strategic plan.